Remodeling the Immune Landscape in Breast Cancer Leptomeningeal Disease Using Dendritic Cell Therapy is an Effective Treatment and Protects Against Disease Recurrence.

Leptomeningeal Disease (LMD) occurs in 5% of advanced stage breast cancer (BC) patients, with an overall
survival measured in weeks. While there is an unmet need for better treatment strategy, the knowledge about
the biology of LMD in general is scarce. Novel approaches with a better understanding of this disease will benefit
in developing a cure. Here we propose using polarized conventional Type I dendritic cell (cDC1) therapy (as a
therapeutic and a vaccine) where cDC1s are primed with HER2 and HER3 to treat HER2+ BC and triple negative
BC (TNBC) associated LMD. In murine models & clinical trials of systemic breast tumors we have found that
class II HER2/HER3 peptide-pulsed Type I polarized cDC1s could partially restore anti-HER2 Th1 immune
responses, which are CD4+ and CD8+ T cell dependent with pathologic CRs in BC patients. This represents a
significant knowledge gap as we need to better understand novel therapies as proposed here. In replicated
preliminary studies we found intrathecal (IT) delivery of HER2 and HER3 peptide-pulsed cDC1s significantly
prolongs the survival in HER2+ and TNBC-LMD models with cures of 70% and 30%, respectively. The antitumor
effect elicited by IT cDC1s is induced by a Th1 CD4+ T cell response. More importantly, most of these cured
mice also resisted BC-LMD rechallenge, suggesting an immunological memory. Hence, the potential of this
therapy as an effective treatment and prevention of LMD is intriguing. A first in person clinical trial of IT cDC1
therapy in LMD is currently accruing (IND27748; NCT05809752), highlighting the promising impact of our
proposal. To understand the mechanisms of its treatment/prevention effects and evaluate combinatorial
strategies we hypothesize IT delivery of cDC1s remodels the immunosuppressive environment in the cerebral
spinal fluid (CSF) and target LMD by producing an IFN-g mediated proinflammatory Th1 response that is CD4+
T cell dependent, and orchestrating a multilayered immune responses which include antibody secretion by B
cells, ADCC by NK cells, and flipping myeloid-induced immune suppression. In Aim 1 we will determine the
cellular/cytokine mechanism(s) of responses to cDC1s using various genetic and pharmacological/antibody
approaches to interrogate innate and adaptive immune responses. Common pathways between murine models
and patients will be identified. In Aim 2 the mechanism(s) by which cDC1s induce long-term memory immune
responses in LMD will be determined. In Aim 3, we will determine whether anti-LMD effect by cDC1 therapy
could be enhanced by coupling with therapeutic IgG1 antibodies. Collectively, these findings will help develop
clinically relevant strategies to treat LMD and optimize secondary prevention for potential disease occurrence.

Public health relevance
There are no effective therapies for Leptomeningeal Disease (LMD) in Breast Cancer (BC). Here we investigate a novel cellular immunotherapy of HER2/HER3 peptide pulsed conventional Type 1 dendritic cells (cDC1s) administered intrathecally as an experimental therapeutic of BC-LMD. We will determine the cellular requirements for responses in LMD, their mechanism of prevention of the disease, and cDC1 combinatorial treatment with therapeutic antibodies to enhance efficacy.